A Novel high resolution MS platform for high-throughput screening of G protein-coupled receptors

Summary: Mass spectrometry (MS) has proven invaluable in studying the mechanisms of cellular
signaling as MS platforms can directly provide amino acid residue site-specific phosphorylation
data compared to traditional antibody-based approaches. However, limitations exist in current
MS approaches in generating confident site-specific phosphorylation quantification. This is
particularly evident in complex multi-phosphorylated protein motifs, where the detection of
isomeric multi-phosphorylated peptides easily overwhelms any prediction scoring approach that
is simply based upon the fragmentation spectra. There are many biological examples of
hyperphosphorylated regions, where they are associated with receptor/ligand interactions,
including G-protein coupled receptors (GPCRs), membrane receptors that are the most common
targets for FDA-approved drugs. For accurate site-specific quantification of protein
hyperphosphorylation we propose a transdisciplinary approach using ultrahigh resolution Ion
Mobility Separation (IMS) integrated with highly accurate and sensitive MS and MS/MS spectra
to enable the confident characterization of hyperphosphorylated GPCR ensembles with greatly
improved sensitivity, and speed. We will use multi-level Structures for Lossless Ion Manipulations
(SLIM) technology (SLIM-Orbitrap platform) to fully characterize phosphorylation of
GPCR/antagonist interactions utilizing CXCR3, which plays a central role in inflammatory
diseases through its regulation of T cell function as an initial test case. We plan to first integrate
ultrahigh resolution IMS with an advanced Orbitrap MS platform for unambiguous decoding of
hyperphosphorylated sites, evaluate the SLIM-Orbitrap MS platform for resolving
hyperphosphorylated protein regions, and finally, perform comprehensive site-specific
phosphoproteomics for GPCRs through screening of activated T cells with dose-responses of
chemokine and small-molecule CXCR3 biased agonists.

Public health relevance
Narrative: G-protein coupled membrane receptors are the most common targets for FDA-approved drugs, and their patterns of protein phosphorylation contain the information required for their activation and function. However, it is challenging to characterize these complex hyper-phosphorylated regions with accurate site- specific identification and quantification. We propose to develop and apply an ultrahigh resolution mass spectrometer using ion mobility spectrometry which will enable the necessary resolution and sensitivity to elucidate these complex hyperphosphorylated regions of proteins.